Metabolic regulation of regulatory T cells through fatty acid metabolism during viral pneumonia

PROJECT SUMMARY
Regulatory T cells (Tregs) are a subset of CD4+ T cells that maintain immune self-tolerance and mediate the
resolution of lung injury during viral pneumonia by suppressing overexuberant inflammatory responses and
facilitating tissue protection and repair. During viral infection, the lung microenvironment imposes substantial
metabolic stress on Tregs. Tregs depend on mitochondrial oxidative phosphorylation, a process driven by fatty
acid metabolism, to optimally exert their function. While there is evidence that Tregs have the potential to be
clinically efficacious as a cellular therapy for patients with severe viral pneumonia, there is a need to ascertain
the context-specific metabolic mechanisms that promote Treg function to enhance their therapeutic activity.
Carnitine palmitoyltransferase I A (CPT1A), the rate-limiting enzyme in long chain fatty acid (LCFA) oxidation,
imports LCFAs into the mitochondria where they are oxidized to acetyl-CoA to enter the tricarboxylic acid (TCA)
cycle to drive oxidative phosphorylation. While established in the extreme microenvironment of tumors, it is
unknown whether Tregs depend on LCFAs for their function during viral pneumonia and whether short chain
fatty acids (SCFAs), which fuel oxidative phosphorylation by providing acetyl-CoA for TCA use, are able to sustain
Treg function in LCFA-limited contexts. In preliminary experiments, we bred mice with Treg specific deletion of
CPT1A (TregCPT1AKO) and challenged them intratracheally with influenza A and subcutaneously with B16F10
melanoma tumors. While TregCPT1AKO mice exhibit no signs of autoimmunity at homeostasis, they are more
susceptible to mortality from severe influenza pneumonia and exhibit slower tumor progression compared with
controls. These results suggest that CPT1A is dispensable to maintain homeostatic self-tolerance but is
necessary for Treg function during pathologically-induced microenvironmental mitochondrial stress. Therefore,
we hypothesize that Tregs require CPT1A-mediated mitochondrial LCFA metabolism to provide lung
tissue protection following severe viral pneumonia. We will causally test this hypothesis by studying mice
with Treg-specific deletion of CPT1A in the influenza A mouse model of viral pneumonia. Our Specific Aims are
1) to determine whether CPT1A-mediated long chain fatty acid oxidation is necessary for Treg tissue-protective
function during influenza A virus pneumonia and 2) to determine whether long chain fatty acids enter the
mitochondrial TCA cycle and whether short chain fatty acids are sufficient to maintain acetyl-CoA levels in and
function of LCFAO-deficient lung Tregs during influenza A pneumonia. The PI will benefit from the collective
intellectual and technical expertise of their mentorship committee—comprised of experts in immunology,
metabolism, epigenetics, and lung disease—who will provide him with project support and mentorship throughout
the funding period. The resource-rich environment afforded to the PI is equipped with all necessary facilities,
equipment, and expertise to complete the research strategy and training plan.

Public health relevance
PROJECT NARRATIVE Regulatory T cells (Tregs) are immune cells that suppress inflammation and protect lung tissue from damage during viral pneumonia. Metabolic factors control Treg function, so ascertaining specific metabolic mechanisms through which Tregs protect from lung damage is necessary to develop therapies that improve outcomes for patients with severe viral pneumonia. Hence, our proposal seeks to understand how therapeutically targetable metabolic factors determine Treg function in the inflamed lung during viral pneumonia.